Interactions underlying resilient bacterial communities and successful colonization of host niches

Bacteria naturally inhabit different niches in the human host, such as the gut, and can opportunistically colonize
sterile niches, such as tumors. Bacterial success in these complex environments depends on multiple factors
that include the niche conditions and interactions with neighboring microorganisms. Our research leverages on
genetically tractable model systems to study bacterial communities in vitro and bacterial colonization of host
niches in vivo. We apply an interdisciplinary approach that combines functional genomics, computational
analysis, and mathematical modeling to study these complex and dynamic systems.
The first focus area is on investigating the factors that underly the complex spatial and temporal patterns
observed in natural bacterial communities. Building on our previous work, we will use genetically engineered
bacteria to implement mutualistic and competitive interactions and test how specific community properties
emerge and change as a function of interaction parameters. Specifically, we will investigate how parameters of
the community members dictate the spatial patterns that emerge when multi-member colonies form. We will
also investigate the temporal patterns that form in cross-feeding communities and their capacity to support
multi-member communities that are not exclusively co-dependent (often observed in nature). Addressing these
questions in genetically tractable bacterial consortia will allow to disentangle some of the hidden rules that
sustain complex microbial communities found in natural niches, such as the human gut. Resolving these rules
will allow genetically engineering robust consortia for biotechnological and biomedical applications.
Our second focus area is on bacterial colonization and adaptation to different host niches. Specifically, we will
investigate bacterial colonization in an existing microbiome niche – the intestinal tract, and bacterial takeover of
a sterile niche – solid cancer tumors. Work will use collections of thousands of bacterial mutants as well as
collections of thousands equally fit wild-type E. coli clones tagged with DNA barcodes. Mutant collections allow
inferring the bacterial pathways and processes needed for successful colonization while collections of equally
fit clones allow inferring the dynamics of a bacterial population experiencing uniform selection. Measurements
of bacterial load and clone (barcode) diversity in different colonization stages will be used to determine
population bottlenecks, growth and death rates, and for evaluating alternative mathematical models of niche
takeover. Our work will deepen the understanding of selection forces operating in the intestinal niche and will
uncover, for the first time, the selection forces and population dynamics that govern bacterial infection of solid
cancer tumors, an area in the field of tumor-microbiome research that is highly underexplored.

Public health relevance
Bacteria naturally inhabit different niches in our body, such as the gut, and can opportunistically colonize sterile niches, such as cancer tumors. We will study how bacteria interactions with the host niche and with neighboring bacteria influence bacterial growth and colonization success. We will identify strategies for promoting the growth of beneficial bacteria.